Early infant affinity toward screens

ABSTRACT
With near-ubiquitous adoption of screen media among U.S. families, the average age of screen media
exposure is becoming increasingly younger. Most infants are exposed to screen media by 4 months of age and
75-96% of infants are using screen media daily. The scale of screen media adoption underscores a pressing
public health need to characterize infant screen media exposures, predictors, and effects. Despite decades of
research highlighting the importance of the infants’ role in shaping caregiving behaviors, the contribution of
infant characteristics to screen media exposures is greatly under-explored. Indeed, the National Academies of
Science has highlighted that more attention needs to be paid to individual differences to screen media effects,
given that not all children experience adverse impacts from screen media. Prior work has identified that infants
likely have individual differences in their affective and behavioral response to screen media. However, only
infant temperament has been explored as a predictor of screen media outcomes. Drawing from a parallel
literature of obesity, detailed observational assessments of infant regulatory behaviors in eating contexts are
stronger predictors of obesity than temperament alone. More rigorous and nuanced assessment of infants’
attentional, affective, and regulatory responses to screen media is urgently needed to move the science
forward. This assessment would create a corpus of observable infant symptoms that predict individual
differences to screen media. Therefore, this proposal seeks to test a novel paradigm characterizing infants’
behaviors during screen viewing, to be termed infant affinity toward screens. Specifically, this project will
measure an infant’s attraction to screens, changes in visual attention, body movement, affect, and calming
when viewing screen-based videos, in addition to negative affect during the transition away from screen media.
The study will leverage a diverse existing cohort of infants in a longitudinal study (K23 HD105988) to test these
predictors of infant affinity toward screens. This project will also test prospective associations with maladaptive
screen media behaviors to identify at-risk infants. Among 100 mother-infant dyads, the aims are to: 1)
characterize infant affinity toward screens in a behavioral task at 9 months of age; 2) identify infant
temperamental and maternal predictors of infant affinity toward screens; 3) test prospective associations
between infant affinity toward screens at 9 months of age and maladaptive screen behaviors at 12 months of
age. This proposal will identify clinically relevant infant behaviors that shape screen media outcomes, salient
aspects of an infant’s early environment that contribute to infant affinity toward screens, and potential targets
for intervention to prevent maladaptive outcomes. In future work, this paradigm could be applied to scale in
pediatric clinics, home visitation programs, and parent-child interventions. In summary, careful behavioral
phenotyping of infant affinity toward screens has high translational impact to identify at-risk infants and
precisely inform future interventions that shape healthy trajectories of screen media use.

Public health relevance
NARRATIVE The goal of this proposal is to characterize infant screen media behaviors using a novel behavioral paradigm, which we term “infant affinity toward screens.” The proposed work will inform our understanding of the infant contribution toward screen media behaviors, will identify infants at greatest risk for experiencing maladaptive screen media outcomes, and could provide novel targets for future intervention.